Illuminating the evolutionary history of colorectal cancer metastasis: basic principles and clinical applications

Background. Metastasis to vital organs is the cause of death in a large majority of cancer patients. Although it
is of eminent clinical importance to understand how systemic disease evolves, metastasis remains one of the
least understood aspects of cancer progression. We still do not have the answers to many fundamental
questions: Are metastasis founders a random selection of cells from primary tumors in which all cells have
essentially equal metastatic ability? Or do specialized metastatic clones evolve, perhaps in intermediate
sanctuary spaces like regional lymph nodes, and then proceed to colonize distant body parts? Are metastases
formed late in tumor progression, by highly evolved and aggressive clones that are the winners of many years
of selection within the primary tumor? Or can metastases already be formed early in tumor development, by
less evolved tumor cells? If both scenarios exist, would such “early” metastases behave differently from “late”
disseminating tumor cells? Method. We have developed a methodology to reconstruct a cancer's evolutionary
history with great accuracy. Our method relies on the analysis of insertion/deletion mutations in hypermutable,
non-coding polyguanine repeats. The lineage information encoded in these sequences is unusually rich:
genotyping of only a few dozen repeats can outperform exome sequencing for phylogenetic reconstruction.
Using polyguanine fingerprinting, we have recently shown that regional lymph node metastases are not the
source of liver metastases in most colorectal cancers, in contrast to a widely held paradigm. Aims and Impact.
Here, we propose to build upon these results and further elucidate critical events in the evolution of metastatic
colorectal cancer. We will determine if lethal distant metastases in the lungs evolve from specialized metastatic
clones that reside in the colonic lymph nodes. We have previously established that 65% of liver metastases are
seeded directly from the primary tumor, but the anatomy of the gastrointestinal vasculature suggests that this
percentage could be significantly lower for other distant metastases. If this hypothesis were confirmed, our
understanding of the role of the lymphatics in colorectal cancer would be fundamentally altered. Second, we
present preliminary data indicating that distant metastases whose evolutionary trajectory diverged from the
primary tumor in early progression stages are considerably less aggressive than metastases that emerge in
later stages. We propose to study and confirm this phenomenon in a large patient cohort. The successful
outcome will be a simple, cost-effective test to predict long-term survival in a subset of patients with metastatic
cancer. Since some patients can survive for years or even decades in spite of metastatic disease, while others
die within weeks of diagnosis, such risk stratification would be of substantial benefit to both patients and their
care providers.

Public health relevance
The evolution of metastasis in colorectal cancer is poorly understood. Fundamental questions regarding the role of lymph node metastases in systemic progression, and the time point of divergence between primary tumor and distant metastases await resolution. Here, we will apply novel genetic approaches to study the evolutionary history of colorectal cancer metastasis in human patients.